Prefrontal Modulators of Stress-induced Extinction Impairment in Female Rats

Project Summary Abstract:
Although women have twice the incidence of developing post-traumatic stress disorder (PTSD),
the identified neurobiological mechanisms that increase the susceptibility of female animals to
stress-induced fear extinction impairment are limited. Abundant studies show that the infralimbic
cortex (IL) is critical for proper fear extinction recall. To begin to address this gap, adult female
rats were exposed to single prolonged stress (SPS) and the animals that showed impaired
extinction recall were identified. The rats that were susceptible to stress-induced extinction
impairment exhibited distinct proteomic changes in IL compared to rats that showed good
extinction recall. Although many of the identified proteins, including neurogranin and microtubule
associated protein tau (MAPT), are involved in neuronal function and synaptic plasticity, their role
in stress-induced extinction impairment is unknown. In this proposal, we will build on our
preliminary findings to further validate the proteomic findings and examine the role of IL
neurogranin and MAPT in susceptibility to impaired extinction recall after exposure to traumatic
stress in female rats. The goal of this proposal is to compare, through robust experimentation, the
mechanisms by which prefrontal neurogranin and MAPT expression contribute to impaired fear
extinction after traumatic stress in female rats as an important step toward understanding
prefrontal mechanisms that alter susceptibility to impaired extinction after exposure to traumatic
stress in females. Our central hypothesis is that exposure to traumatic stress alters neurogranin
or MAPT expression in the IL of susceptible rats leading to reduced excitability of IL neurons and
impaired fear extinction recall in females. To address this hypothesis, the team will examine the
relationship between IL neurogranin and MAPT expression and impaired fear extinction after SPS
exposure in Aim 1. In Aim 2, they will determine if reducing the expression of neurogranin or
MAPT in IL enhances fear extinction and alters IL neuronal excitability. The overall impact of these
Aims will greatly increase the understanding of the mechanisms by which exposure to traumatic
stress can hinder fear extinction and highlight the role of changes in neurogranin, MAPT, and the
IL proteome in this process. This data will enhance NIH’s mission to identify the neurobiological
basis for complex behavioral responses to trauma and potentially lead to novel treatments.

Public health relevance
Project Narrative: Our understanding of the molecular mechanisms that determine susceptibility to stress-related disorders after trauma exposure in females is limited. The goal of this proposal is to examine the mechanisms by which prefrontal proteomic changes contribute to impaired fear extinction after traumatic stress in female rats. Completion of this goal will enhance NIH’s mission to identify the neurobiological basis for complex behavioral responses to trauma.